GROWTH/BLOOD BIOCHEMISTRIES OF PRETERM INFANTS FED WITH HUMAN OR FORTIED MILK

The objective of the study is to compare the growth and serum indicators of nutritional status between two (2) groups of preterm infants fed either human milk supplemented with a commercial powdered HMF or an experimental powdered HMF. The weight gain per kg per day will be a primary variable in this study. It will be analyzed by fitting linear regression to daily weights for each subject separately.